The intersection of immunity and cardiovascular diseases

PROJECT SUMMARY
The overall goal of the Intersection of Immunity and Cardiovascular Disease (IICD) Program Project Grant is to
understand how immune cells are activated and contribute to target organ damage in hypertension and
autoimmune diseases. Our overarching hypothesis is that activated immune cells promote renal and vascular
dysfunction and damage, promoting vascular and renal disease, blood pressure elevation and worsened
autoimmunity. Robust experimental and clinical data indicate that Isolevuglandins (IsoLGs) formed in these
conditions alter enzyme and transcription factor function and form antigens that stimulate T cell activation and
autoantibody formation. Project 1 director Dr. Harrison has identified specific peptide antigens, and
characteristics of class 1 human leukocyte antigens (HLAs) that present these antigens. He will identify T cells
and T cell receptors common to experimental hypertension, SLE and psoriasis. The ability of HLAs to present
IsoLG-adducted peptides will be evaluated and an unbiased assay will be employed to discover peptides that
can activate T cells in human hypertension. In project 2 Dr. Annet Kirabo’s team will examine how salt stimulates
IsoLG formation in human salt sensitivity and in the hypertension associated with SLE. She will characterize salt
sensitivity using a well-accepted inpatient protocol, and then randomize subjects to a trial of 2-hydroxybenzamine
(2-HOBA) for 4 weeks to determine if this improves salt sensitivity and vascular function in these subjects. Dr.
Kirabo has developed an innovative animal model involving adoptive transfer of peripheral blood mononuclear
cells from humans with SLE to immunodeficient mice, which leads to blood pressure elevations and albuminuria.
Preliminary data indicate that salt feeding exacerbates disease in this model, and she will determine if
scavenging IsoLGs is protective in these animals and in humans with salt sensitivity. Dr. Michelle Ormseth, the
director of Project 3, will conduct a 20-week randomized, placebo-controlled, double-blind, cross-over proof-of-
concept phase II study to determine the effect of scavenging IsoLGs with 2-HOBA in humans with SLE. Our
early-stage investigator (ESI) and director of Project 4, Dr. Matthew Alexander, has found a marked renal
accumulation of granulocytes in a mouse model of psoriasis that is associated with increased cutaneous IL-17A,
renal damage and blood pressure elevation. He will define the role of interleukin 17A, IsoLG formation and
granulocytes in the hypertension and renal disease observed in these animals using tools employed by other
IICD investigators. A major goal of the IICD is to ensure success of our ESI, and we have created a mentoring
plan and set aside funding that will enhance his scientific development. The IICD PPG will be supported by an
administrative core (Core A), which will also provide biostatistical guidance for all projects, and an Analytical and
Biochemical core (Core B) that will provide essential assays and reagents for all projects. Overall, this IICD PPG
will provide new understanding of the molecular mechanisms of inflammation in hypertension and autoimmune
conditions and identify new therapeutic targets to reduce morbidity and mortality in these devastating illnesses.

Public health relevance
Project Narrative Autoimmune diseases increase the risk of cardiovascular disease through mechanisms that are not understood. This program will examine causes of tissue and organ injury in hypertension and autoimmune diseases like systemic lupus erythematosus and psoriasis, and will attempt to discover new treatments for these conditions.